Mechanisms regulating the plasticity of postmitotic cells in mammalian retina

PROJECT SUMMARY/ABSTRACT
One of the promising strategies to treat retinal diseases is to generate desired neuronal types, which are
damaged or lost during disease, and develop cell replacement-based therapies. A comprehensive
understanding of how distinct retinal types are formed during development can greatly inform these therapeutic
strategies. While mitotic retinal progenitor cells (RPCs) are thought to be intrinsically different, the fates of
retinal cells are not determined in RPCs. Many newly born postmitotic cells are still plastic. It is currently not
clear how newly born postmitotic cells attain their final fate states. We propose to uncover the genes and
pathways that regulate fate decisions in newly born postmitotic cells during development and determine
whether they can also promote cell reprogramming in adult retina.
We collected genes that are enriched in newly born postmitotic cells in the retina based on published
single cell RNA-seq data, and developed novel methods to study their function specifically in newly born
postmitotic cells in vivo by utilizing retroviral-based genetic approach and light sheet microscopy. A zinc finger
transcription factor Myt1 (Myelin transcription factor 1) was found to be enriched in newly born postmitotic cells,
but not RPCs, during development; it can promote neurogenesis, especially the formation of bipolar cells, while
repressing glial fate in newly born postmitotic cells at neonatal stages. We hypothesize that Myt1 ensures the
neuronal fates in newly born postmitotic cells and can contribute to neuronal reprogramming in mature retina.
In the proposed studies, we will test this hypothesis through two aims. In Aim1, we will elucidate the function of
Myt1 in fate determination, and test the hypothesis that Myt1 promotes bipolar cell fates by titrating down, but
not completely shutting down Notch signaling pathway, and by actively repressing glial genes in newly born
postmitotic cells. In Aim2, we will determine whether Myt1 together with Ascl1 and Brn2 can promote direct
reprogramming of Müller glial cells into neurons in mature mouse retina.
Taken together, this proposal aims to elucidate the plasticity of postmitotic cells in mammalian retina. We
will focus on understanding how zinc finger transcription factor Myt1 promotes specific neuronal fates in newly
born postmitotic cells during development and determining whether Myt1 can enhance neuronal
reprogramming from glial cells in mature retina. This work will improve our understanding of basic biology and
provide new candidate genes and possibilities for the regeneration of retinal neurons. Notably, mutations in
human Myt1 gene are associated with Oculo-Auriculo-Vertebral Spectrum diseases, which are developmental
disorders with ocular defects such as microphthalmia. Elucidating the function of Myt1 in retinal development
can also shed light on the disease mechanisms.

Public health relevance
PROJECT NARRATIVE The proposed study aims to uncover the plasticity of postmitotic cells in mammalian retina. We will focus on understanding how zinc finger transcription factor Myt1 promotes neuronal fates in newly born postmitotic cells during development and determining whether Myt1 can enhance neuronal reprogramming in mature retina. This work will improve our understanding of the retina and provide new candidate genes and possibilities for the regeneration of retinal neurons.